Multiscale tools and approaches for understanding and engineering cell-fate transitions

Project summary
Synthetic biology aims to harness the power of biological systems to dynamically access information in
the cell, enabling synthetic biomedical tasks such as tumor surveillance, pathogen identification, or cell-fate
reprogramming. Such tasks in cellular engineering rely on robust mechanisms to regulate transgenes for the
delivery of enzymes, genetic corrections, and cellular therapies. To unleash its full potential, mammalian
synthetic biology requires foundational tools for implementing reliable control of gene expression in primary cells.
For example, transgene silencing (e.g. loss of expression) remains a common challenge to effectively
engineering primary cells. Layers of regulation across a range of length- and time-scales coordinate events from
molecular binding to cell signaling regulate gene expression and thus cell fate. Multiscale approaches are
needed to integrate the diverse processes that control cell-fate transitions. Cell-fate transitions represent pivotal
events requiring coordination of multiple processes from epigenetic and cytoskeletal remodeling to proliferation
and transcription. Understanding these transitions may illuminate how oncogenes coopt these processes to drive
cellular transformation. Here, we propose a multiscale approach for understanding and engineering cell-fate
transitions (e.g. reprogramming, differentiation).
From our previous work to identify principles of cell-fate transitions, we identified systems-level
constraints that limited reprogramming and developed a cocktail that increased reprograming 100-fold in mouse
cells. Comparing the human and mouse response to reprogramming, we identified species-specific differences
in proliferation, signaling, and the innate immune response during reprogramming that may contribute to lower
reprogramming rates for human cells. We propose to examine these molecular correlates to determine how each
impacts the reprogramming process and outcomes. We will use these insights to design genetic controllers to
guide cells through reprogramming. Already we have identified a strategy to optimize reprogramming by inducing
a transient “erase” phase followed by a “write” phase to establish the new cell fate. We propose to develop
controllers capable of autonomously guiding cells through these competing objectives to enhance the efficiency
of reprogramming. Genetic controllers are composed from synthetic gene circuits connected to native gene
regulatory networks. While significant efforts have been devoted to the logical design of enhanced synthetic
circuitry (e.g. circuits for synchronized quorum sensing, edge-detection), less is understood regarding how
cellular hardware and the emergent three-dimensional structure of genetic elements affect circuits. Here, we
propose to improve our understanding how transcription reshapes DNA and how it impacts the performance of
gene circuits. Defining the role of chromatin structure in cellular identity will guide molecular engineering efforts
to build genetic controllers capable of regulating behavior. We anticipate that the principles and tools we develop
will be broadly applicable across cellular engineering applications as well as for investigating cell-fate transitions.

Public health relevance
Project narrative This project aims to develop foundational tools for cellular engineering that will enable robust cell-fate programming. Using a combination of stem cell biology, systems biology, synthetic biology, and chromatin engineering, we will define the molecular regulatory rules of cell-fate transitions. Harnessing these design rules will enable the forward design of sophisticated genetic programs capable of robustly regulating gene expression in primary cells to support gene- and cell-based therapies for application in regenerative medicine.